Training Program in Comparative Effectiveness Research for Suicide Prevention

Project Summary
This application is being submitted for a new Training Program in Comparative Effectiveness Research for
Suicide Prevention that will be offered by the Department of Epidemiology at the Harvard T.H. Chan School of
Public Health with predocs also coming from the Department of Psychology in the Faculty of Arts and Sciences
(FAS) at Harvard University and postdocs from the Department of Psychiatry at Harvard Medical School
(HMS). The principal objectives of the Training Program will be to educate a new generation of promising
interdisciplinary pre- and post-doctoral trainees in the use of cutting-edge methodology for comparative
effectiveness research (CER) focused on clinical and policy interventions aimed at reducing suicides and
suicide-related behaviors (SRBs; ideation, plans, attempts, other self-injurious behaviors). The application
builds on the combined strengths of the epidemiologic methods program in the Epidemiology Department and
the strong collaborative research program on suicide prevention across several Departments at Harvard. We
aim to train subject matter specialists (clinical psychologists, psychiatric epidemiologists, psychiatrists) in
cutting-edge CER methods and to provide trainees who are going to become CER methodologists with the
intensive subject matter exposure in suicide prevention research needed to encourage their continued focus on
suicides and SRBs in their future studies. All trainees will complete a rigorous core set of courses in modern
CER methods as well as receive in-depth training in current theories and empirical CER studies aimed at
preventing suicides and SRBs. An extensive network of collaboration exists among training faculty members
with each other and with external collaborating in numerous high-profile CER studies focused on interventions
to reduce suicides and SRBs. These projects will provide trainees with a rich array of mentored research
training opportunities. We are requesting support for a total of six trainees: three predoctoral and three
postdoctoral. Training will be a combination of coursework, training seminars led by core faculty, practica, and
mentored research training in which CER methods are applied to important projects involving the prevention of
suicides and SRBs. Diversity and health disparities will be major foci.

Public health relevance
Project Narrative Scientific advances in addressing the rising suicide rate in the U.S. will require high-level interdisciplinary research that takes advantage of the increasing availability of big data to investigate the comparative effectiveness of alternative interventions prior to carrying out expensive and time-consuming large-scale controlled treatment trials or community interventions. The next generation of suicide prevention researchers will need to be comfortable using the advanced designs and analysis methods of comparative effectiveness research (CER) and appreciate the importance of addressing under-represented populations and recognizing the role played by health disparities in suicides and SRBs in order to address the rising U.S. suicide rate. We aim for our proposed Training Program in Comparative Effectiveness Research for Suicide Prevention to advance these goals by bringing together and cross training a talented group of epidemiologists and clinical predocs and postdocs who will become the vanguard of a new generation of sophisticated CER suicide prevention researchers.